Elucidating the chemical biology of the druggable targets in enteric pathogens C. jejuni & E. coli

This proposal’s objective is to elucidate the chemical biology of microbial metabolites and small molecules
to specifically target intestinal pathogens, which cause intestinal infection & inflammation. The findings will
facilitate the development of intervention strategies to specifically control the emergence and spread of
antibiotic resistance in this significant human pathogen without altering the entire gut microbiota.